Tulane National Primate Research Center

Project Summary – Overall
The Tulane National Primate Research Center (TNPRC) is affiliated with Tulane University of Louisiana and
was dedicated in 1964. The Center is part of Tulane University Health Sciences along with the School of
Medicine, the School of Public Health and Tropical Medicine, and the School of Science and Engineering. The
TNPRC is one of seven NIH-supported National Primate Research Centers within the National Primate Research
Center Program. This application requests funding for the five-year time-period of May 1, 2023-April 30, 2028.
Funds will be used to support administration, operations, animal resources, scientific research resources, a pilot
research program, alteration and renovations, outreach, and education and training activities of the Center. The
animal resources program is fully accredited by AAALAC with exemplary status. Significant infrastructure
projects have been completed including renovation of new laboratory space and completion of the PET/CT
facility within the RBL. We have completed a large infrastructure upgrade with upgraded boilers and new and
increased capacity chillers, new building automation and access controls and energy efficiency lighting
upgrades, as well as upgrades in stormwater and wastewater treatment improvements.
The period since the last renewal of the TNPRC base grant has been a time of sustained growth and
programmatic change. Total funding for the Center has increased to more than $43.8M in FY2021. The TNPRC
is the only NPRC to have a Regional Biosafety Laboratory (BSL-3), which has been a key factor in obtaining
funds to support numerous studies utilizing select agents, tuberculosis, and emerging infectious diseases,
including a new and expanding program in SARS-CoV-2 research. Our efforts in SARS-CoV-2 have provided
leadership within the NPRC system with the development of nonhuman primate models, testing therapeutics
and vaccines. In addition, we developed a CoVID-19 Coordinating Center and Data Center supported by NIH,
which provides coordinated and collaborative interactions with other NPRCs. The development of our strong
Quality Assurance and Quality Control Program and new High Containment Research Performance Core have
contributed greatly to our success during this funding period. In the next grant period, we will recruit additional
faculty and expand our research efforts into chronic and comorbid conditions associated with infections and
aging. We will focus on building onto our current successes with the generation of a new strategic plan that will
make TNPRC the best primate center we can be and a premiere place to work for our employees.

Public health relevance
Project Narrative – Overall The Tulane National Primate Research Center (TNPRC) has a mission to improve human and animal health through basic and applied biomedical research. The Center serves as a national resource for biomedical research that requires the use of nonhuman primates. Hundreds of NIH-funded investigators each year rely on the resources of the TNPRC to conduct their research.